DCTD - Predictive Drug Testing in Organoid Models

The Division of Cancer Treatment and Diagnosis, NCI is requesting the high-throughput screening (HTS) of approved and investigational agents in organoid models established from patient-derived tumor tissues. These studies will assist NCI in identifying drug responsive tumors and enable the active investigation of the underlying mechanism(s) of action, predictive biomarkers of response and/or resistance to agents, and the effects of genetic alterations on drug efficacy. This project focuses on the use of organoid models to predict the efficacy of anti-cancer agents in various tumor types for further pre-clinical investigation by the NCI.